Multifunctional EPRI Instrument to Advance Therapies in Biomedical Sciences

Abstract:
Electron paramagnetic resonance imaging (EPRI), where electron spins are the subject of the investigation, is a
promising tool and has the ability to provide maps of multiple tissue microenvironment parameters, such as
partial oxygen pressure (pO2) and pH. However, currently, there is no instrument available that can provide
multi-parametric maps due to very different requirements on the instrument hardware. Current
instrumentation, such as a 25 mT pulse EPRI instrument JIVA-25Ô developed by us, only provides pO2 maps
and does not provide images of other parameters as its hardware does not support the continuous wave (CW)
acquisition methods needed for imaging pH. In the current project, our goal is to develop a multifunctional
imager (MFI) that can perform both pulse and CW acquisition for simultaneous pO2 and pH imaging. Towards
this goal, we will develop a 25 mT Halbach-type permanent magnet (Aim 1), new muli-modal transmit-receive
electronics based on field programmable gate array (FPGA) (Aim 2), and finally, we will build the MFI instrument
(Aim 3). Our long-term goal is to make functional imaging affordable to scientists in biomedical fields to enhance
therapies and understand biology.

Public health relevance
Narrative Physiological parameters such as oxygen and pH that define the tissue microenvironment affect multiple pathologies, from cancer and inflammation to wound healing. This project will develop a multifunctional continuous wave and pulse mode electron paramagnetic resonance imager to obtain three-dimensional maps of oxygen and pH.